The STEMfluidics Platform: Inspiring STEM Learning and Career Exploration with Microfluidics

Project Summary:
Modern educators struggle to maintain student interest and participation in Science, Technology, Engineering,
Math, and Medicine (STEMM), partially due to lack of truly transformative, hands-on laboratory experiences
that build real-world STEMM skills. Microfluidics, with its extensive interdisciplinary applications in medical
diagnostics, pharmaceutical development, academic research, energy, electronics, and nutrition, represents a
valuable and underutilized opportunity to teach relevant 21st-century STEMM techniques that are essential for
the future high-tech workforce. Despite its growing role in our daily lives, particularly through rapid point-of-care
medical devices, environmental remediation, and consumer electronics, microfluidics lacks resources for the
educational laboratory. Market research shows that existing microfluidic systems are too expensive and fragile
for teaching laboratories, while homemade solutions lack the rigor and reproducibility necessary to be effective
interventions.
To address these issues, we propose the STEMfluidics platform, a classroom-focused microfluidics system that
will revolutionize STEMM education. This innovative device features an integrated hardware platform with fluid
pumps, interchangeable sensors, and touchscreen controls, enabling students to perform safe and easy
microfluidics experiments in the classroom. Students conduct experiments by placing a custom microfluidic
chip onto the platform and connecting the sensors. STEMfluidic chips will feature a combination of
microchannels, mixing chambers, and fluid ports tailored to the concepts being taught. The prefabricated chips
simplify setup, ensure reproducibility between student groups, and reduce costs to the school, enabling
educators to teach microfluidics effectively. The hands-on experimentation allows students to develop a
practical understanding of microfluidic concepts and their utility in our daily lives.
The platform is enhanced through hands-on microfluidic experiments featuring topics relevant to students,
including fluid dynamics, medical disparities within communities, and the importance of point-of-care
microfluidics for rapid disease diagnosis. Comprehensive educational materials will train students in data
collection and statistical analysis, enabling them to expand the knowledge gained from the STEMfluidics
experiments into their daily lives. These resources will include print, video, and interactive digital materials that
relate the importance of microfluidics in human health and consumer technology. To evaluate the practicality of
these resources and the STEMfluidics platform, we will convene a focus group comprising STEMM educators
at K-12 and university levels to provide feedback on the prototype progress and classroom implementation.
Taken together, the STEMfluidics platform, experiments and associated materials will provide educators with
an inexpensive and accessible pathway to introduce innovative, quantitative biotechnology to students.

Public health relevance
Project Narrative There is a critical need for transformational educational technologies in high school and college laboratory courses to equip students with real-world science, technology, engineering, math, and medicine (STEMM) skills. Given its cross-discipline utility, we believe that microfluidics represents a valuable yet underutilized opportunity to teach relevant 21st-century STEMM techniques that are essential for the future high-tech workforce. This proposal details the development of STEMfluidics – an affordable, robust, and student-friendly microfluidics platform – and a collection of experiments designed to help educators teach microfluidics while exploring critical topics in human health.